2025 Charleston Conference on Alzheimer's Disease Reunion

ABSTRACT
2025 Charleston Conference on Alzheimer's Disease Reunion
April 6- April 10, 2025
The proposal seeks support for the upcoming 2nd Charleston Conference on Alzheimer's Disease Reunion
(CCADR), which is to be held from April 6 to April 10, 2025, at the San Juan Fairmont Hotel in Puerto Rico. The
conference is poised to bring together established researchers and promising new scientists in the field of
Alzheimer's disease (AD) research. The CCADR provides a rare opportunity for early, mid-career researchers
and senior scientists from diverse academic backgrounds to collaborate on AD studies. The goals for the 2nd
CCADR include: 1) Provide a platform of colloquy for scientists from varied fields of study to discuss one
main disease; 2) Facilitate active participation, prioritizing early-career scientists to present and network;
3) Catalyze new ideas and innovative research directions; and 4) Promote collaborative efforts. The
conference stands out for its unique ability for reconnecting alumni from a decade of the Charleston Conference
on Alzheimer’s Disease (CCAD), forming a network that has significantly contributed to collaborative research.
This strong foundation has proven to be a catalyst for co-authored publications and the acquisition of research
grants. The forthcoming event aims to build upon this success by facilitating even more impactful discussions,
increasing research funding, leading to more publications, and importantly, driving the development of new
therapeutic strategies to combat AD.

Public health relevance
PROJECT NARRATIVE 2025 Charleston Conference on Alzheimer's Disease Reunion April 6- April 10, 2025 Alzheimer's disease (AD) presents a significant economic and public health challenge, with the U.S. allocating over $250 billion for its management in 2023. Despite the prevalence of AD, affecting over six million Americans, the disease's fundamental mechanisms remain elusive, complicating efforts to create effective diagnostics and treatments. The urgency for groundbreaking research is critical, and initiatives like the Charleston Conference on Alzheimer's Disease Reunion are instrumental in gathering experts to accelerate the development of meaningful treatments.